Evaluating the effectiveness of a mobile HIV prevention app to increase HIV and STI testing and PrEP initiation among rural men who have sex with men

Abstract
Uptake of HIV and STI testing among gay and bisexual men who have sex with men (GBMSM) in the rural
southern US is low. However, HIV and STI testing is a fundamental gateway to preventive services, such as
pre-exposure prophylaxis (PrEP), and treatment provision. Thus, it is critical that we identify methods to
increase uptake of HIV and STI testing among this population that experiences disproportionate HIV and STI
incidence. We have developed an app, Combine, that is an adaptation of HealthMindr, an app that has
demonstrated efficacy in increasing uptake of HIV testing among urban GBMSM. Combine was adapted using
input from GBMSM in rural areas to address issues specific to this population such as increased experiences
of stigma and reduced access to culturally competent care. We propose to conduct a Type 2 Hybrid
Effectiveness-Implementation randomized controlled trial to test the efficacy of Combine to increase uptake of
HIV and STI testing over 24 months of follow-up and to examine the effect of different implementation
strategies among GBMSM in the rural South. Combine will include components for self-administered risk
assessments, developing and supporting a plan for frequent HIV and STI testing, information about PrEP, and
PrEP and HIV/STI testing provider locators. Previous trials of app-based HIV prevention have included the
ability to order free HIV and STI self-test kits. However, there is not a consensus among health officials around
whether at-home self-tests are an optimal solution for increasing HIV and STI testing. Additionally, despite the
availability of free HIV and STI self-test kits in previous studies, large proportions of men still do not complete
HIV tests and even fewer complete STI tests. Thus, we will evaluate the effect of two different intervention
components on HIV and STI uptake in a 2x2 factorial trial design: availability of HIV and STI self-test kits
ordered through the app and a motivational interview designed to enhance the existing app content, increase
self-efficacy to develop and follow through with a testing plan, and develop strategies to deal with experiences
of stigma. All participants will receive the Combine app, including a locator to identify nearby HIV and STI
testing centers. Men in the control arm (Arm 1) will not have the ability to order HIV and STI self-test kits and
will not receive a motivational interview; men in Arm 2 will not have the ability to order HIV and STI self-test kits
but will receive a motivational interview; men in Arm 3 will be able to order free HIV and STI self-test kits but
will not receive a motivational interview; and men in Arm 4 will have the ability to order HIV and STI self-test
kits and will receive a motivational interview. We will assess the main effects of the availability of HIV and STI
self-test kits and the motivational interview on HIV and STI testing uptake, PrEP initiation, and intervention
maintenance over 24 months of follow up. Our community-based partner, Engaging Arkansas Communities,
will work with us through all stages of the project to ensure that we are obtaining the necessary data to inform
future implementation.

Public health relevance
Project Narrative Gay and bisexual men who have sex with men (GBMSM) in the rural southern United States experience a disproportionate incidence of HIV and STIs. Despite this, HIV and STI testing uptake and pre-exposure prophylaxis (PrEP) initiation remain low among rural GBMSM. We propose a type 2 hybrid effectiveness- intervention randomized controlled trial to test the efficacy of a mobile app, Combine, to increase the uptake of HIV and STI testing and PrEP over a 24-month period among GBMSM in the rural South and to assess the effects of different implementation strategies on intervention maintenance.